CATALYTIC ASYMMETRIC SYNTHESIS OF BETA AMINO ACIDS

Beta-Amino acids are important building blocks of peptide drugs and small molecule drugs. The research will focus on the new asymmetric synthesis of beta-amino acids. Through the studies of catalytic asymmetric synthesis of beta-amino acids, those amino acids should be more directly and easily obtained than with current technology. Additionally, as a catalytic process this method of production of beta- amino acids will be environmentally friendly and result in lower prices for these products, thereby expanding their applicability. The goal of phase I is to obtain the optically pure amino acids through catalytic asymmetric synthesis. We will explore the potential of a new concept in the enantioselective synthesis of amino acids, enantiomer-selective activation of racemic catalysts. In phase II we will build on these results to expand the reaction scopes and enlarge the scales to production capacity. PROPOSED COMMERCIAL APPLICATION: New enantiospecific syntheses of beta-amino acids will expand the gallery of reasonably priced peptide drug precursors and offer the pharmaceutical industry a new arsenal of building blocks for producing peptide drugs for the treatment of AIDS, cancer.